Concerns about genetic discrimination: Origins and Effec

The purpose of this study is to explore the nature, extent and effect of consumers' concerns about genetic discrimination among people enrolled in a hereditary colorectal cancer research registry. The specific aims are: 1. To demonstrate the nature and extent of consumers' concerns about genetic discrimination, 2. To describe the factors (i.e., media coverage, personal/family experience, information given by health professionals, education level, extent of family history) which are associated with concerns about genetic discrimination, 3. To assess consumers' awareness and understanding of current legislative protections against genetic discrimination in employment and insurance, 4. To explore the extent to which concerns about genetic discrimination may influence decisions about genetic testing.